Instrumentation Module

ABSTRACT
Instrumentation Module
The Instrumentation Module provides design, fabrication and modification capabilities for project-specific,
customized and software-flexible vision research apparatuses that are not commercially available. During the
past five years, the Module fabricated many in-house, tailor-fitted and specially-designed devices that have
played crucial roles in generating many high-impact and innovative vision research results. In the next grant
period, this Module will continue its indispensable role in supporting vision research projects by providing new
mechanical, electronic, optic and computer-based design and fabrication services and to develop highly
innovative, high-impact research tools, such as the chronically implanted recording chambers, the customized
in-house construction of a 8-patch-electrode micromanipulator/recording system, two-photon microscope
systems, LED white-noise stimulating system, and the forced-choice, optokinetic reflex machine. All these
devices will be constructed and repeatedly modified, fitted and adjusted before and during experiments by the
in-house machine shop and electronic/optics/computer shop. Therefore the Instrumentation Module is not only
a necessity of many Vision Core labs, but also an integrated part of the research process and scientific
progress.

Public health relevance
NARRATIVE Administrative Module The Core Grant for Vision Research is directed by Samuel M. Wu, PhD, who will be assisted by a Core Grant Advisory Committee, consisting of himself, module directors Drs. Pflugfelder, Ching-Kang Chen and Rui Chen and an Administrative Associate, Ms. Jessica Nollkamper. The Vison Core provides support and facilities which are not available or cannot be obtained through individual grants to 24 vision research investigators at Baylor College of Medicine. The facilities in the Core modules will be used to study how visual system disorders, such as retinitis pigmentosa, age-related macular degeneration, glaucoma, amblyopia and strabismus occur and to determine what neuronal and synaptic mechanisms in the visual system are responsible for the pathogenesis of these disorders.